Administrative Core

PROJECT SUMMARY – Administrative Core
The Administrative Core will assure that the NCIBT meets the annual milestones for the Center established in
collaboration with its NIBIB program officers. It will oversee and coordinate the scientific and administrative
operations of the Center’s activities and foster interactions and synergies among the Technology Research and
Development projects (TRDs), collaborative projects (CPs), and service projects (SPs). It will oversee the
technology training and dissemination (TTD) activities. It will also coordinate interactions with the Internal
Advisory Board (IAB), External Advisory Board (EAB), Training Leadership Council (TLC) and with the NIH-
NIBIB and oversee the Center’s relationship with the Sponsoring Institution (UC Davis Office of Research)
including marshalling and deployment of institutional support. The responsibilities of the Administrative Core
extend over six main areas (Specific Aims) as follows: Aim 1. Design, populate and enable an organizational
structure conducive to efficient and effective direction of the NCBIT. The Administrative Core will oversee and
the NCIBT functions: communication, programmatic operations, management of its computational infrastructure,
and interactions both internal and external. Aim 2. Establish and maintain center operating procedures. The Core
will delineate and seek compliance with standard NCIBT’s operating procedures. These will incorporate best
demonstrated practices of both business administration and scientific investigation including compliance from all
parts of NCIBT with the Center’s policies regarding communications, personnel management, financial transfers
and accounting, and evaluation and reporting. Aim 3. Facilitate communication, coordination and data sharing
among the Center’s components, with the NIH, and with external entities. The Core will oversee all
communication, both administrative and scientific, internal and external to the Center. This includes coordinating
interactions among the TRDs, CPs, SPs, and TTD program, with the NIH, the host and other participating
institutions, teams wishing to join NCIBT, and the public. Aim 4. Supervise the interactions of the Center with its
CPs and SPs. The Administrative Core will develop criteria for selecting and continuing CPs and SPs. It will
annually assess the progress of each TRD and every TRD-CP and TRD-SP relationship to identify additional
strategies for partnership. It will evaluate and approve TRD requests for sharing equipment and resources with
the CPs and SPs. Aim 5. Convene an External Advisory Board (EAB) and an Internal Advisory Board (IAB). Aim
6. Marshall and manage Institutional Support. The Administrative Core is responsible for all interactions with the
host institution. Foremost among these is obtaining, utilizing, and deploying support in the form of space, funding,
and in-kind assistance with education, training, and other forms of dissemination of NCIBT technology.